Assessing Clinical Effectiveness and Implementation of Worksite Sleep Health Coaching in Firefighters

Background. Cardiac events are the leading cause of death among firefighters and occur while on-duty at an
alarmingly high rate. Short, disrupted sleep is a major, modifiable risk factor for cardiovascular disease (CVD),
and up to 40% of firefighters experience sufficiently severe sleep disruption to screen positive for sleep
disorders. Cognitive behavioral therapy for insomnia (CBTi) is well-established as efficacious and effective
within health care settings. However, the effectiveness of CBTi-informed sleep health coaching and sleep
health promotion in workplace settings, and among firefighters specifically, is largely unknown. Theory-driven
research is required to address this research-to-practice gap and also identify facilitators to and barriers of
intervention implementation in this high-risk population.
Goal. The primary objective of this proposal is to examine whether a scalable, CBTi-informed intervention,
firefighter sleep health coaching (ffSHC), improves sleep disturbances when implemented in a real-world, high-
demand work environment.
Methods. This study proposes to conduct a stepped wedge cluster randomized controlled trial in order to
examine the effectiveness of an evidence-based sleep health coaching intervention delivered to 400 career
firefighters across 20 fire departments (Aim 1). The primary outcomes are (a) the pragmatic PROMIS Sleep
Disturbances questionnaire and (b) the multidimensional sleep health index derived from actigraphy.
Secondary and tertiary outcomes include: sleep related impairment, sleep continuity, blood pressure, heart
rate, and long-term clinic-assessments of cholesterol, body mass index, and blood pressure. To advance
implementation science, this project will employ the Integrated Promotion Action on Research Implementation
in Health Services (iPARIHS) framework to guide a mixed methods formative evaluation (Aim 2a) of
intervention adaptations and implementation strategies. A theory-based process evaluation (Aim 2b) is
embedded within the clinical trial to explore combinations of factors that promote agency-level implementation
and to inform future implementation research in public safety settings.
Significance and Innovation. This research will accelerate the translation of sleep health intervention to
workplace wellness and advance implementation science through the application of the iPARIHS framework.
The use of sleep health coaches is innovative and models how programs may expand reach to address the
global problem of insufficient sleep. The long-term goal of this research is to provide critical knowledge that
facilitates the widespread implementation, dissemination, and sustained utilization of sleep health intervention to
promote continuous, sufficient sleep and ultimately mitigate CVD risk. Achievement of study goals will improve the
health and wellness of firefighters, a population whose health is vital to assuring public safety and supporting
community resiliency.

Public health relevance
NARRATIVE Insufficient sleep is a major global public health concern that places people at increased risk for negative health, including cardiovascular disease; unfortunately, many individuals and occupations at heightened risk for sleep disturbance, like firefighters, are limited in their ability to identify and access evidence-based intervention. This project aims to increase access to sleep health intervention by testing and implementing an evidence-based sleep health coaching program within the fire service. The results of this study will identify factors that are key in the adoption of sleep health intervention to inform the implementation and dissemination of sleep health workplace wellness programs nationally.